Biosynthetic Pathways in Cardiac Remodeling

The ability of the heart to use multiple substrates provides the flexibility needed to balance catabolic demands
with anabolic requirements; however, the failing heart shifts its energetic reliance toward glucose, and has
diminished fuel flexibility. This switch in fuel use is associated with pathological remodeling, but it remains
unclear how increased reliance on glucose catabolism affects cardiac health. We propose the general
hypothesis that the inability of the failing heart to spare glucose-derived carbon for biosynthetic reactions
causes pathological remodeling. We find that several collateral biosynthetic pathway metabolites are higher in
the compensatory phase of hypertrophy, and that reductions in their abundance coincide with the early stages
of heart failure. Nevertheless, how cardiac metabolic pathways are inter-regulated remains unclear, and how
changes in metabolism elicit myocardial responses to stress remains unanswered. To span such gaps in
knowledge, we will examine how collateral biosynthetic pathways change with cardiac remodeling in vivo by
using deep network stable isotope tracing after pressure overload. We will also examine how physiologic
stimuli for cardiac growth regulate cardiac biosynthetic pathway activity. We will correlate the changes in
biosynthetic pathways with catabolic pathway activity. In Aim 2, we will determine how changes in the cardiac
catabolism modulate collateral biosynthetic pathway activity in the heart. For this, we will force glucose, fat, or
ketone oxidation using pharmacological and genetic approaches and measure glucose carbon fate in anabolic
pathways using deep network stable isotope tracing. Under controlled metabolic conditions, we will construct
an atlas demonstrating how glycolysis, mitochondrial activity, and substrate availability affect glucose carbon
fate and anabolic pathway activity in cardiomyocytes. In Aim 3, we will augment biosynthetic pathway activity
by genetically or allosterically regulating key metabolic steps in the heart or by introducing enzymes to activate
metabolic pathways that are not typically operational in the mammalian heart. We will determine how these
interventions regulate cardiac metabolism and affect myocardial structure and function during pressure
overload-induced heart failure. We will delineate how these interventions affect the metabolism-guided
decisions in cell signaling and gene expression that modulate cardiac hypertrophy and heart failure. Thus, this
project will provide fresh perspectives about how metabolism regulates cardiac health and could identify
innovative metabolic approaches to control cardiac remodeling. In particular, these studies will integrate our
current understanding of cardiac catabolism with new knowledge of how cardiac anabolism is regulated in the
heart. Such insights are conceptually novel and will contribute to understanding how metabolism regulates
cardiac hypertrophy. Thus, these studies will identify: the metabolic pathway flux configurations that occur
during different forms of ventricular remodeling; how fuel selection in the cardiomyocyte regulates anabolic
metabolism; and new metabolic approaches to prevent deleterious remodeling.

Public health relevance
The high metabolic demands of the healthy heart are normally satisfied by its intrinsic metabolic flexibility. During heart failure, however, metabolic inflexibility emerges and may underlie the deterioration of cardiac function. In this project, we will test how metabolic pathways are coordinated in healthy and diseased hearts, with the goal of creating new understanding of cardiac pathophysiology.